CHARM 2: Chemotherapy for ablation and resolution of mucinous pancreatic cysts: a prospective, randomized, double-blind, multi-center clinical trial

Pre-malignant pancreatic cysts that are difficult to characterize and treat are increasingly
discovered in the US over the last two decades due to advances in imaging and an aging
population. With the incidence of highly lethal pancreatic cancer rising in the US, intervening on
pancreatic cysts with malignant potential in a safe and effective way is a major public health
concern. While patients have been historically limited to radiographic surveillance or potentially
hazardous surgery as undesirable methods of managing these cysts, endoscopic ultrasound
guided fine needle injection (EUS-FNI) has emerged as a less-invasive, safe and effective
method of early intervention. For EUS-guided treatment of pancreatic cysts today, care typically
includes lavage with ethanol. However, experts agree that adverse events (AEs) observed
during treatment are due to ethanol use. Recently, based on the safety concerns surrounding
ethanol use, as well as the promising treatment findings linked to the infusion of paclitaxel, our
team created an ethanol-free (EF), combination chemotherapy treatment consisting of an
admixture—paclitaxel and gemcitabine—specifically designed to target pancreatic cystic
neoplasia by EUS-guided injection. Our team completed testing of this novel treatment strategy
in 2017 as a preliminary randomized trial, showing that EF lavage (i.e., saline) with combination
chemotherapy was as effective, and far safer, than the same chemotherapy treatment with the
inclusion of ethanol lavage (EL). In this proposal, our aim is increase the scale of our pilot study,
conducting a large and definitive multi-center trial that will be the first funded RCT to compare
treatment with EL to ethanol-free (EF) treatment with combination infusion of chemotherapeutic
agents. All subjects will have qualifying cystic lesions aspirated and evacuated, and undergo a
follow-up procedure at 3 months and final imaging at 12 months. We will randomly assign 100
adult patients with pancreatic cysts to two study arms: (1) Ethanol lavage (EL): EL, followed by
infusion of a paclitaxel-gemcitabine admixture, or (2) Ethanol Free (EF): saline lavage, followed
by infusion of the same paclitaxel-gemcitabine admixture. We hypothesize that EF treatment will
result in significantly fewer adverse events and will have complete cyst ablation resolution rates
that are not inferior to EL treatment. If the EF intervention proves to be non-inferior to, and
significantly safer than, treatment with EL, it will validate EUS-FNI as a viable treatment modality
for intervening on pre-malignant cysts and will change the standard of care for pancreatic cyst
management. Critically, if EF treatment is successful, it may alter the treatment decisions that
patients make and change the treatment options that centers of excellence offer.

Public health relevance
Public Health Relevance Pancreatic cysts with potential for malignancy are increasingly diagnosed in US adults and, even though endoscopic ultrasound guided fine needle injection (EUS-FNI) with ethanol lavage (EL) has emerged as a less–invasive treatment of these cysts, experts agree that adverse events observed during treatment are due to ethanol use. Over the past decade, however, infusion of cysts with chemotherapeutic agents have been proven effective and, most recently, our team concluded a small preliminary randomized trial showing that ethanol-free (EF) lavage with combination chemotherapy was as effective, and far safer, than treatment with ethanol lavage. In this randomized controlled trial (RCT), we will conduct a larger, more definitive study of the EF approach to treatment and, if the EF intervention proves to have efficacy non-inferior to, and safer than, treatment with EL, it will validate ethanol-free, EUS-guided combination chemotherapy as a safe and effective treatment modality for intervening on pre-malignant cysts with the potential to change the standard of care for pancreatic cyst management.